Rectal evacuation disorders and straining-associated symptoms in bleeding hemorrhoids

Hemorrhoidal bleeding is one of the most frequent medical complaints and serves as the most clinically
relevant presentation of hemorrhoids that leads to several million gastroenterology referrals each year in the
US. A typical patient is empirically treated with fiber and topicals; US patients spend $10 billion annually on
fiber and topicals. Unfortunately, >50% of patients do not respond to fiber. Guidelines recommend maximizing
conservative options prior to hemorrhoid ligation and ineffective straining is a recognized cause of
hemorrhoids. Yet few treatments for ineffective straining exist other than to “stop straining”. Rectal evacuation
disorders leading to ineffective straining can be identified with formal anorectal function tests and treated with
pelvic floor physical therapy in related populations with chronic constipation, but evidence to support this
approach in populations with hemorrhoid bleeding as a conservative option prior to hemorrhoidal ligation is
limited. Even if evidence were developed, access to formal anorectal function testing remains limited to a
handful of specialized centers. We recently developed and prospectively validated the ability of a simple, novel
point-of-care device (RED) to predict treatment outcomes with subsequent pelvic floor physical therapy. We
will conduct a clinical trial among 100 patients with hemorrhoidal bleeding in general gastroenterology. In
Research Aim 1, we will evaluate the severity of global constipation symptoms on the Patient Assessment of
Constipation Symptoms (PAC-SYM) questionnaire, of which hemorrhoidal symptoms are one component, as
well as global hemorrhoid symptoms using the Hemorrhoid Disease Symptom Score (HDSS). In Aim 2, we will
evaluate the prevalence of rectal evacuation disorders and concurrent validity between point-of-care and
laboratory-based anorectal function tests as objective biomarkers reflective of ineffective straining among
patients with hemorrhoidal bleeding in a subset of patients. The results of this award will inform the design of
future intervention trials to test novel predictive tests to inform conservative management of hemorrhoidal
bleeding with pelvic floor physical therapy.

Public health relevance
Hemorrhoidal bleeding leads many patients to see a gastroenterologist, yet options are limited in clinical practice between fiber supplementation and hemorrhoid ligation/surgery. This study will help many patients gain new conservative, non-surgical options with pelvic floor physical therapy to treat hemorrhoidal bleeding and inform the design of future clinical trials.